Roles of Recycling Endosomes in Neuronal Extracellular Vesicle Cargo Traffic

PROJECT SUMMARY
The goal of this proposal is to understand how cellular membrane trafficking machinery controls the packaging
and release of extracellular vesicle (EV) cargoes from synapses in vivo. EVs are small membrane-bound
vesicles released by numerous cell types, including neurons, carrying cargoes critical for signaling and
disease. However, we understand very little about how EV cargo traffic is spatially and temporally regulated
within the polarized and complex morphology of neurons. We have developed tools to track and manipulate EV
traffic at Drosophila presynaptic terminals in vivo, and discovered that flux of cargoes through a plasma
membrane-recycling endosome route determines whether they are locally sorted for packaging and release in
EVs, rather than depleted from synapses by retrograde transport. Recycling endosomes have primarily been
studied in non-neuronal cells, and very little is known about their lifetime, functions, or dynamics at presynaptic
terminals. We do know that recycling endosomes play critical roles in signaling, neuronal morphogenesis, EV
traffic, and synaptic transmission. Understanding and therapeutically intervening in these important processes
will require a deeper knowledge of the mechanisms of neuronal recycling endosome function. In this proposal,
we will elucidate the mechanisms of synaptic EV cargo and recycling endosome traffic in vivo. To achieve
these goals, we will use Drosophila genetics, biochemistry, high-resolution microscopy, and live cell imaging.
1) We will determine the functions, dynamics, and regulation of different types of synaptic recycling
endosomes. To this end, we will develop new tools and approaches to define and control functionally distinct
recycling compartments at synapses. Using these tools, we will test novel mechanistic hypotheses for how
membrane traffic machinery sorts cargoes at synaptic recycling compartments. 2) We will determine how EV
cargo traffic depends on distinct modes of synaptic endocytosis: clathrin-mediated endocytosis, which operates
under low neuronal activity and activity-dependent bulk endocytosis, which operates during intense neuronal
activity. These experiments will ascertain if EV fate is determined by different modes of internalization, how
recycling endosomes contribute to these functions, and provide new mechanisms to link activity, endosomal
traffic, and EV release. Given the conserved nature of synaptic membrane trafficking machinery, our findings
and tools will lay the foundation for new insights into EV traffic in many aspects of nervous system function,
including in human neurological disease.

Public health relevance
PROJECT NARRATIVE Neurons can communicate with each other via electrical and chemical signals, as well as membrane-bound packets called extracellular vesicles. These vesicles carry cargo that can contribute to normal brain function, but in neurological disorders including Parkinson’s and Alzheimer’s Diseases, they can also spread toxic proteins throughout the brain. Our research will help us understand how extracellular vesicles are packaged, released and spread in the nervous system, and may identify new strategies to treat a wide variety of neurological diseases.